Targeting the endothelial clock to treat perioperative myocardial ischemia

Myocardial ischemia (MI) is one of the leading causes of death worldwide. Currently, the mainstay therapy of
acute MI remains early revascularization. However, reperfusion injury following revascularization is a
significant cause of myocardial damage. In fact, 1-year mortality rates are as high as 42% in patients
undergoing revascularization after perioperative MI. While endothelial damage has been recognized as a
critical contributor to myocardial IR-injury, no endothelial-protective strategy has been established yet.
We recently pioneered a novel role for the light elicited circadian rhythm protein Period 2 (PER2) in
protection from MI. Investigation of light exposure strategies to target and manipulate PER2 function revealed
that housing mice under intense instead of ambient light conditions for one week (14h light:10h darkness,
10,000 LUX, full-spectrum with UV filter) mediates robust cardioprotection. As the underlying mechanism, we
discovered that intense light enhanced the circadian amplitude of cardiac PER2. Unexpectedly, subsequent
studies revealed that this ‘amplitude enhancement’ of PER2 established a cardioprotective and hypoxia
inducible factor 1 alpha (HIF1A)-similar signaling environment in the uninjured heart. Circadian amplitude
enhancement has been implicated as a protective mechanism in different settings and is currently under
intense investigation. However, the underlying mechanisms are not well understood. A whole-genome array on
intense light elicited gene regulation uncovered that intense light upregulated the HIF1A-regulated and
endothelial-protective Angiopoietin-like 4 (ANGPTL4) protein in the uninjured heart. This discovery pointed
towards a critical role for endothelial expressed PER2 in light-elicited cardioprotection. Indeed, using mice with
endothelial-specific deletion of Per2, we demonstrated that light elicited cardioprotection was completely
abolished. Moreover, intense light pretreatment significantly improved endothelial barrier function following
myocardial ischemia, which was endothelial PER2 specific. Therefore, we hypothesize that amplitude
amplification of endothelial PER2 boosts vascular integrity via induction of HIF1A-ANGPTL4 which improves
myocardial function in MI. To address this, we designed three specific aims: 1. Define drug-elicited PER2 as an
endothelial-barrier-protective strategy in MI, 2. Study drug induced HIF1A to increase the circadian
amplitude and to overcome Per2 deficiency, 3. Study endothelial ANGPTL4 as a downstream target of
intense light elicited cardioprotection.
The main goal of these studies is to characterize novel, light-based therapeutic targets that can be
modified pharmacologically and are as effective as an intense light treatment in cardioprotection. By
investigating novel endothelium-targeting strategies, this proposal promises to identify new, high-impact
therapeutic approaches for post-ischemic myocardial protection that could effectively be used to prevent or
attenuate ischemic tissue injury of the myocardium in patients undergoing major surgery.

Public health relevance
Damage of endothelial cells significantly contributes to myocardial injury during myocardial ischemia. Observations that intense light pretreatment represents a therapeutic strategy in myocardial ischemia pointed us towards a critical role for a light-regulated circadian rhythm protein in endothelial barrier protection. By using novel tissue-specific knockout mouse models and time-of-day guided drug therapy in vivo in combination with circadian-mechanistic studies, we hope to identify novel drug-based therapies that could substitute light and effectively treat endothelial dysfunction following myocardial ischemia.